The effects of HIV-associated extracellular vesicles on mitochondrial dysfunction in brain microvessels

Combined antiretroviral therapy (cART) suppresses HIV replication, but 30-60% of infected patients suffer from
severe HIV-1 associated neurocognitive disorders (HAND). However, the mechanisms underlying HAND are
unclear and this lack of information has prevented the development of effective science-driven treatments. Our
data have provided key information connecting etiology, especially by showing that pathogenic contents of
plasma extracellular vesicles (EVs) from either chronic SHIV-infected and cART treated rhesus macaque (RM)
or HIV(+)–cART treated patients play a key role in the development and progression of HAND. Moreover, our
novel findings provide the first evidence that EVs released by HIV-replication defective cells (HIV-EVs) cause
dysfunction and damage to the primary human brain microvascular endothelial cells (HBMECs) and disrupt
blood-brain barrier (BBB) function via a mitochondrial-dependent mechanism. These results are consistent with
our non-human primates and mice studies, which shown that brain microvessels (MVs: end arterioles, capillaries,
and venules) composed primarily of endothelial cells, are more vulnerable due to SIV-infection and exposure to
HIV-EVs, respectively. Additionally, our data suggest that neuroinflammatory protein fibrinogen (Fgn) and HIV-
Tat are abundant in HIV-associated EVs, which impairs mitochondrial function and ATP production in BMECs
by preventing normal mitochondrial fission/fusion events via direct inhibition of dynamin-related protein 1 (DRP1),
thereby reducing energy production and increasing oxidative stress. These detrimental mitochondrial effects
lead to endothelial cell damage, disruption of the BBB, impaired blood flow regulation, and cognitive impairment.
Interestingly, we observed that EVs released by mesenchymal stem cells (MSC-EVs) rescued the HIV-EV/Fgn-
mediated mitochondrial dysregulation and BBB leakage in HBMECs. Our focus on cerebral MVs is appropriate
since this segment of the circulation is increasingly recognized as an initiation site for the progression of many
neurological diseases, including HAND. Our overall hypothesis is that HIV verion free EVs accelerate cerebral
microvascular endothelial and BBB dysfunction by inducing mitochondrial dysregulation. Moreover, we propose
that MSC-EVs could protect endothelial mitochondria in live mice. We will explore EV-mediated BMEC/BBB
dysregulation in cerebral MVs of humanized NOD/SCID/IL2Rγnull (NSG) mice. In Aim 1, we will determine the
effects of HIV-free EVs on mitochondrial and BBB dysfunction in brain microvasculature of NSG mice. In Aim 2,
we will establish the EV-containing fibrinogen and HIV-Tat dependent mechanism for mitochondrial and BBB
dysregulation in cerebral MVs of NSG mice. In Aim 3, we will establish the therapeutic potential of MSC-EVs to
reverse the EV-mediated mitochondrial and BBB dysfunction in cerebral MVs of NSG mice. Vascular
contributions to cognitive impairment and dementia (VCID) are an integral part of HAND. The NIH has designated
VCID as a critical research area and our application is highly relevant for this research area.
1

Public health relevance
PROJECT NARRATIVE Despite the efficacy of combined antiretroviral therapy (cART), the development of HIV-1 associated neurocognitive disorders (HAND) is a serious clinical complication in AIDS patients. The mechanisms underlying HAND are underdeveloped, and the current cART regimens are insufficient to inhibit the progression of HAND. We propose to elucidate the role of extracellular vesicles (EVs) on brain microvascular endothelial mitochondria in the development of HAND and evaluate the clinically tested mesenchymal stem cell-derived EVs to prevent neuropathogenesis in the HIV-1 infected humanized mice model. 1